12th Biennial Symposium of the International Eosinophil Society, Inc. (IES)

CONFERENCE ABSTRACT
R13 conference support is requested for the 12th Biennial Eosinophil Symposium, “Eosinophils 2023”, to be held
July 11-15, 2023 at the David Braley Health Sciences Centre, McMaster University, Hamilton, ON, Canada under
the auspices of the International Eosinophil Society, Inc. (IES). The meeting hosts ~35 invited speakers and
~120 additional participants who submit abstracts. A cutting-edge program of basic, translational and clinical
research is being prepared by the IES Scientific Program Committee in consultation with the Local Organizing
Committee. Planned sessions include: 1) regulation of eosinophil development and trafficking, 2) eosinophils in
tumor immunology and cancer therapy, 3) eosinophils in tissue injury/repair/fibrosis in organ disease, 4)
eosinophil regulation of local immunity and interactions with innate and adaptive cells, 5) cell death (and stress,
autophagy) in eosinophil biology, 6) reciprocal interactions between eosinophils and microbiomes in gut
homeostasis/dysbiosis, 7) eosinophils in GI diseases, 8) eosinophils in host defense; anti-bacterial and viral
responses including COVID-19, 9) eosinophils in dermatologic diseases, 10) novel technologies for studying
eosinophils in health and disease, and 11) current status and future of eosinophils as therapeutic targets. The
overarching goal is to provide a highly interactive, interdisciplinary forum for scientific exchange amongst junior
and established scientists in the fields of allergy, immunology, microbiology, hematology, and cancer in relation
to the eosinophil’s roles in health and disease. A primary objective is bringing together basic scientists with
expertise in eosinophil biology, and clinician investigators interested in eosinophil-associated diseases, to
improve understanding of disease mechanisms, significance of eosinophil functions, and foster translational
research. A 2nd objective is to foster the development and interests of younger investigators to help support their
career development, creating a new generation of “eosinophiles”. The meeting has a Keystone-like-structure
with all participants in a single conference venue for unopposed sessions. Both the scientific and social programs
emphasize creating a global community for eosinophil scientists. This meeting is particularly timely because new
data and approvals of biologic therapies that directly or indirectly block eosinophil-mediated development and
inflammatory pathways are now providing definitive findings on the roles of eosinophils in human health and
disease. The symposium, with its strong emphasis on inter-disciplinary research, covers important global
diseases including asthma, eosinophilic esophagitis, parasitoses, hypereosinophilic syndromes and COVID-19.
The format includes plenary and poster sessions, with the former covering state-of-the-art topics by leaders in
the field, followed by cutting edge presentations on recent high impact studies, with oral abstract presentations
integrated into the sessions. Two unopposed poster sessions include short presentations of high-impact studies.
Two prize lectures are included, the Ehrlich Award for a scientist who has made a major overall contribution to
the field, and Gleich Award for a scientist with the highest impact publication over the previous two years.

Public health relevance
Narrative – Public Health Significance Eosinophils are one of the white blood cells that protect us against infections, some cancers, and help with wound healing, but they can also contribute to diseases including asthma. The major focus of the International Eosinophil Society is to organize a biennial meeting, the purpose of which is to provide a venue for ~200 scientists, clinician-investigators, and trainees interested in eosinophils to meet, exchange information and develop collaborations to advance research in the fields of eosinophil biology and pathogenesis of eosinophil- associated diseases. The 12th symposium, to be held in Hamilton, ON, Canada in July 2023, will be particularly exciting, as new data from recently approved biologicals and ongoing clinical trials using novel anti-eosinophilic and anti-inflammatory biologicals and drugs will be available.